NCI, National Clinical Trials Network Lead Academic Participating Site (LAPS) UG1

PROJECT SUMMARY
As reflected in this application, Mayo Clinic has a long tradition of clinical research and has been a supporter
and active participant in the National Clinical Trials Network (NCTN). Support of the NCTN includes formation
of one of the founding organizations (North Central Cancer Treatment Group, now Alliance), Sustained
leadership roles in the NCTN and in clinical trials, as well as active supporters of clinical trials. Multiple Mayo
Clinic staff continue in current leadership roles within the NCTN or NCI sponsored activities related to the
NCTN. Mayo Clinic remains committed to making NCTN trials a prominent part of its portfolio of clinical trials
for cancer patients or patients at-risk for cancer. This commitment is reflected in the prioritization of NCTN
trials over many other trials, the level of accrual to NCTN trials, further refinements to the activation and
monitoring of progress of NCTN trials to ensure their success, the continued leadership role of Mayo Clinic
physicians in the NCTN member organizations, and an on-going commitment of the MCCC to support this
activity. Mayo Clinic physicians and researchers continue to have an active role in not only patient accrual to
NCTN clinical trials, but to leadership in developing and leading trials. Mayo Clinic researchers also continue to
be active in presenting the results of these trials at national and international meetings and high-impact
journals, as described within the current grant application. Mayo Clinic researchers have continued to be active
in performing subsequent analyses of the collected data, and meaningful use of the biospecimens collected
from the trials to transform the science of cancer care. Mayo Clinic has also continued to focus on the
development of junior investigators in the NCTN to ensure the continued active support of NCTN member
organizations and the success of NCTN clinical research. Finally, Mayo Clinic is committed to making clinical
trials available to all patients, regardless of their racial, ethnicity, or socioeconomic background.

Public health relevance
PROJECT NARRATIVE Mayo Clinic has a long tradition of clinical research and has been a supporter and active participant in the National Clinical Trials Network (NCTN). With over 1.3 million unique patients seen each year (of which over 120,000 are patients with cancer), Mayo Clinic is committed to making clinical trials available to all patients regardless of their racial, ethnicity, or socioeconomic background. A major factor in allowing this to occur is through Mayo Clinic's commitment to making NCTN trials a prominent part of its portfolio of clinical trials for cancer patients or patients at-risk for cancer.